Novel Molecules as a Window to Anesthetic Mechanisms

Project Summary
The introduction of general anesthesia for “painless” surgery is one of the largest advancements ever made in
medicine and has transformed surgery from being a barbaric last resort to an event that occurs over 40 million
times a year in US operating rooms (ORs). There is an irony that one of the greatest medical advancements is
still one of the least understood and anesthetics are still said to be among the most dangerous drugs in clinical
use due to their remarkably narrow therapeutic indices. Perhaps related to their toxicity, anesthetics act on many
targets and are likely to have multiple mechanisms of action in addition to agonism of the GABAA receptor.
Identification of a broader cache of anesthetic targets would allow a novel approach to rational design where
multiple targets are actually required. But a challenge is differentiating the many “non-specific” anesthetic
interactions from the mechanistically important (or desirable) interactions. This work seeks to uncover anesthetic
mechanistic targets by exploiting a propofol derivative that was incidentally discovered to antagonize anesthesia,
and use it as a novel approach to the “reverse engineering” of anesthetic action.
My research has blossomed out of observations made with a fluorinated derivative of propofol, called
propofluor (aka fropofol). This molecule, initially hypothesized to be an anesthetic, but instead elicited propofol
antagonism in tadpoles and larval zebrafish. Further experiments strongly suggest competitive antagonism, and
we have now identified multiple additional compounds that have increased antagonistic potency. We have shown
that sensitivity to this antagonist changes throughout early development in parallel with sensitivity to propofol,
but the antagonism only persists until the age of sexual differentiation in zebrafish (21-15 days post fertilization).
Preliminary findings have recapitulated this developmental effect in mice. In addition to further pharmacologic
investigations, we propose to use bifunctional photoaffinity derivatives of propofol and its antagonists to identify
the molecular interactomes during development. The relevance of these targets will be further refined via
comparison to large developmental transcriptomic databases (for mice and zebrafish) that have just recently
become available. This analysis will truncate the list of potential targets so that functional validation in animal
models can be most efficiently pursued. This multidisciplinary program to utilize anesthetic antagonists as
research tools to reveal relevant anesthetic mechanisms represents an entirely innovative approach to the study
of anesthetic mechanisms.

Public health relevance
Project Narrative Despite their frequent use, anesthetics are considered to be some of the most dangerous drugs in clinical use but are not well understood. A subset of propofol analogues have been shown to antagonize propofol-induced anesthesia which may eventually lead to increased clinical safety, but provides a more immediate opportunity to study anesthetic mechanisms from a new perspective. This research program seeks to lay the foundation of understanding this novel class of molecules and leverage this knowledge to learn more about anesthetic mechanisms.